Multi-OMICS identification and validation of mechanisms triggered by Immune interventions aimed at reducing the size of the replication competent Reservoir

ABSTRACT – ADMINISTRATIVE CORE The Administrative core of the P01 program grant entitled “Multi-OMIcs identification and validation of mechanisms triggered by Immune interventions aimed at reducing the size of the replication competent Reservoir “ (Multiomics Immunity Reservoir- MOIR) will provide scientific, fiscal, and regulatory oversight for all components of the P01 program across the participating institutions and clinical sites. This P01 contains 3 Research Projects, an Administrative Core, and a Machine Learning and Modeling Core. The overall goal of the administrative core is to establish an organized research environment that will foster collaborative interactions between investigators, promote innovative research, and meet the key objectives of the P01. The administrative core will thrive to ensure that scientific work plans are performed according to the highest ethical standards and follow the most stringent principles of rigor and reproducibility. The Administrative core will accomplish these goals through the following three specific aims: 1) Create an infrastructure plan for the overall management and coordination of the P01 activities; 2) Provide scientific and fiscal oversight, and generate annual progress reports to ensure that the P01 is in compliance with the stated milestones and timelines; and 3) Facilitate effective communication and foster productive interactions among Projects and Cores. The organizational infrastructure of the Administration core consists of an Administration Core Council (ACC), a scientific steering committee (SC), and a Scientific Advisory Board (SAB). The members of the SC (project and core leaders) will be responsible for scientific oversight, evaluation of program activities, ethical, scientific integrity and regulatory oversight. The ACC members, which consist of the Project and Core Lead PIs of the P01 and the program manager, will coordinate the highly integrative scientific agenda, provide financial oversight, manage data storage and data sharing among the scientific and lay community and establish a centralized website to facilitate communication both within and outside the P01 community. To facilitate interactions between PIs, postdoctoral fellows, students, and research support staff, the administrative core will organize monthly and annual meetings to discuss scientific progress and program activities. In addition, the administrative team will ensure the proper execution and adherence to all contractual agreements (MTA and IRBs) associated with the P01. Together the ACC and SC will serve to maximize the synergy between projects and cores, promote community engagement, assist in resolving conflicts and disputes, and implement a strategic approach to accomplish the Program goals.

Public health relevance
NARRATIVE An HIV cure has been an elusive goal and very hard to reach as most therapies targeting only the virus have failed to create a dent on the infected cell which are hiding from a debilitated immune system. Our project will target all the arms of the immune system in order to restore the immune function that can eliminate those HIV- infected cells.